Homocysteine Stimulates T Cell Activation, Apoptosis and Thymic Involution

Our studies have revealed that treatment of resting and activated human and murine T cells with L-Hcy resulted in a dose-dependent increase in apoptotic cell death. L or D,L Hcy was more potent than Hcy thiolactone in this respect, while SAH was found to be significantly less active. We also found that the pro-apoptotic effects of Hcy were abrogated with the addition of serum, pan-caspase inhibitors, and PARP inhibitors to the cell cultures. These results suggest that D,L-Hcy, like other apoptotic stressors, leads to the activation of the caspase cascade and eventually to the cleavage of the key cellular proteins facilitating the release of mitochondrial cytochrome c, DNA fragmentation, and eventually leading to the typical morphological changes observed in cells undergoing apoptosis. Moreover, we have also found that Hcy appears to potentiate cellular death induced by a number of other established apoptotic signals including activation-induced cell death (AICD), heat shock, and Fas ligand- and HIV-mediated T cell death. Finally, we have also observed that in vivo infusion of D,L Hcy but not SAdy induces thymic involution with a dramatic reduction in thymocyte numbers, thymic weights and a dramatic change in thymic morphology. The specific role of Hcy in age- or disease-associated involution remains to be defined. [unreadable] [unreadable] In addition, we have found that highly-purified human or murine T cells stimulated with immobilized anti-CD3 and/or anti-CD28 mAb in the presence of L-Hcy or thiolactone but not SAdy results in a significant increase in several type 1 but not type 2 cytokines. These effects were also observed upon in vivo infusion of Hcy and within folate deficient mouse models. A more detailed examination of the Hcy effects on T cell activation revealed that this type 1 cytokine production profile is partially mediated through the production of other type 1-associated cytokines and nitric oxide. Moreover, D,L-Hcy but not SAH treatment also resulted in the demethylation of the IFN-gamma promoter permitting the binding of phosphorylated CREB. Given the potent effects of Hcy on methylation, these results may not seem surprising; however, a more detailed analysis of the direct induction of methyltransferase activity, DNA or protein methylation or indirect effects through other mediators and signals needs to be defined. More recent data has suggested that L-Hcy selectively activated Th17 cells based on the cytokine profiles induced in our T-cell cultures. The precise mechanism involved in the generation of these cytokines is currently under investigation but we believe the Hcy effect is being mediated, in part, by specific stress-associated signals post Hcy treatment. Detailed cytokine promoter analysis is currently underway to address the effects of Hcy on transcription factor induction and activation. [unreadable] [unreadable] Overall, Hcy appears to exert a number of differential effects on immune cells, which may alter immune function in the circulation and tissue microenvironment with age and inflammatory and/or autoimmune disease pathology. A greater understanding of the potential modulatory effects of Hcy and its metabolites on immune function may result in the development of potential therapeutic strategies to control and optimize immune responses with age, AIDS and in various age-associated disease states.